Microbiology (TRACK 1- FOOD DEFENSE)

Project summary: The primary goal of MDHHS BOL food laboratory is to provide surge capacity testing for the analysis of food products in detection, identification, and response for emergencies involving biological contamination of food with BSL3 bacterial select agents. BOL also will participate in FDA exercises, surveillance, and special event activities. Objective 1: To foster partnership with FDA stakeholders thereby taking necessary actions to assure the safety and security of the food supply. Objective 2: To collaboratively prepare sustainable testing capabilities and ensure laboratory surge capacity for BSL-3 select agents in food; initiating timely, effective, and well- coordinated response actions. Objective 3: Collaborate with FDA partners in developing a communication plan, to address the vital information need during an event. Objective 4: Participate in FDA-requested exercises and/or surveillance activities and national special event exercises. Objective 5: Maintain preparedness to rapidly respond to suspected or confirmed intentional contamination involving human or animal food. Objective 6: Test a minimum of 50 samples for Yersinia pestis, Bacillus anthracis, or requested organism from FDA. Samples will be collected by laboratory following FDA Chapter 4 Sample Collection Manual. Objective 7: At least one key person will attend LFFM face to face meeting.

Public health relevance
Project Narrative: Comprehensive surveillance activities are essential for the detection of bacterial pathogens in food products, has a tremendous impact in developing public health strategies thereby implementing remedial action for food- borne illness across the State of Michigan. MDHHS BOL is a designated LRN Tier 1 laboratory for select agent testing in the Midwest region. Therefore, the primary goal of this project is to support FDA with food defense exercises and foster collaborative relationship with the federal partners thereby enhancing the surveillance activities for biothreats from food materials collected across the State of Michigan.